Cortical Circuits Underlying Functional Recovery Following Stroke

Project Summary
Stroke is one of the leading causes of long-term disability in the United States. Recovery from
stroke-induced disability affects patients’ long-term quality of life. The goal of the proposed
project is to unravel the circuit mechanisms underlying functional recovery after stroke. We will
employ innovative approaches using state-of-the-art two-photon imaging techniques combined
with optogenetic stimulation in mice. These approaches will allow us to monitor and manipulate
the same neural circuits longitudinally. Through these novel approaches, we will test the
hypothesis that different classes of neurons have different roles in stroke recovery. Our
approach will provide the basis for identifying more effective interventions that promote stroke
recovery through cell-type-specific manipulation.

Public health relevance
Project Narrative Functional recovery from stroke determines the patients’ quality of life. The goal of the proposed project is to unravel the cortical circuit mechanisms underlying functional recovery after stroke. We will employ innovative approaches using state-of-the-art two-photon imaging techniques combined with optogenetic stimulation in mice. Our proposed study will provide pivotal information on how we can manipulate cortical circuits to maximize functional recovery following stroke.